Digital High Resolution Melt and Machine Learning for Rapid and Specific Diagnosis in Neonatal Sepsis

Project Summary
Blood culture sensitivity in neonates is poor but is the “Gold Standard” for the diagnosis of sepsis.
Universal genotyping of pathogen genomic sequences using High Resolution Melt (U-HRM) provides a simple,
low cost, rapid, and modern alternative to blood culture testing. By measuring the fluorescence of an
intercalating dye as PCR-amplified pathogen DNA fragments are heated and disassociate, sequence defined
melt curves are generated with single-nucleotide resolution in a closed-tube reaction. We have advanced U-
HRM into a digital PCR format (U-dHRM), where DNA sequences that are present in mixtures are individually
amplified and identified as is needed for polymicrobial infections. We have also established unique signature
melt curves for 37 bacterial species that commonly infect older children and adults and automatically identify
them using machine learning technology. With the goal of creating an accurate and valid test for the timely
diagnosis of neonatal sepsis, we will advance this technology to identify unique fungal, viral, and bacterial
HRM signatures along with antibiotic resistance genes with an accuracy of 99-100% on minimal blood volume
(1mL). Our aims are: Aim 1. Optimize and assess the U-dHRM platform for neonatal bacteremia diagnosis by
expand our bacterial database (13 additional bacteria) to detect causes of >99% of neonatal bacterial
infections, expand our antibiotic resistance gene database to include five clinically actionable genes, and
assessing the performance of the system for bacteremia diagnosis in mock and clinical whole blood samples;
Aim 2. Advance the U-dHRM platform for simultaneous detection of fungal and viral pathogens by upgrading
our optical system to enable expansion to fungal and viral detection in a high-throughput format, multiplexing
the assay to expand to viral and fungal pathogens causing >99% non-bacterial infections, and conducting
analytical validation of the multiplexed platform using mock whole blood samples; and Aim 3. Advance the
machine learning algorithm for detection of emerging pathogens by developing and integrating an anomaly
detection algorithm for reporting emerging pathogens that are not included in our database and validating the
algorithm using data generated in Aims 1 and 2. Thus, this proposal directly addresses the funding call by
applying a multidisciplinary approach to overcome the biomedical challenge of rapidly diagnosis sepsis, a
hidden public health disaster.

Public health relevance
Project Narrative Digital High Resolution Melting (dHRM) of DNA combined with machine learning creates unique “fingerprints" for microbes and antibiotic resistance, allowing for faster and more precise detection and treatment of pathogen(s) causing sepsis. This project will advance and test the clinical performance of dHRM technology in the diagnosis of neonatal sepsis. Our goal is to rapidly and accurately identify pathogens and their resistance markers to facilitate accurate antimicrobial therapy, reducing antibiotic overuse in non-infected infants.